IAFF Hazardous Waste Worker Training

In alignment with the NIEHS 2018-2023 Strategic Plan, the International Association of Fire Fighters (IAFF)
seeks and encourages opportunities to collaborate with organizations that share the common goal of
protecting workers and their communities. The built environment has become more complex due to increased
population growth, aging infrastructure, and increased use of complex chemicals throughout manufacturing
processes. In addition, workers face a number of emerging issues including occupational cancer risks, stressors
impacting behavioral health and wellness, and provider and community resiliency.
The IAFF proposes to continue its training program to train workers, across multiple disciplines, that may be
called on to manage or mitigate hazardous material incidents in order to prevent work-related harm and
improve worker-related health and safety. The IAFF proposes to deliver eight Hazardous Materials Technician
and eight Confined Space Rescue classes per year, as well as additional refresher training and Train-the-
Trainer modules to ensure program sustainment. During the grant period 16 classes will be held each year,
providing over 25,600 contact hours to 400 workers annually. The IAFF training has a successful history of
development, updating, and delivery of such technical training programs, evidenced by high student pass
rates, highly-rated survey responses, and repeated positive third-party program reviews. The proposed
training will be accessible to all populations that may be responsible for preventing, responding to, or assisting
in recovery of, a HazMat emergency including fire and EMS personnel, law enforcement members, emergency
management and public health officials, industrial responders, as well as local community partners.
Through this continued cooperative agreement, the IAFF will:
1. Utilize advanced GIS and collaborative contact databases to identify and coordinate outreach to target
populations, giving consideration to increasing diversity and training of underserved populations.
2. Enhance the capabilities of workers through the delivery of updated and improved curricula, that includes
embedded training on important emerging topics, to improve overall worker health and safety, and
encourage increased worker and community resiliency.
3. Integrate new technologies (such as electronic tablets, an IAFF online library of tools and resources, mobile
hotspots, web-based applications, etc.) for course delivery, ensuring consistent deployment to all students
while also improving access to technology across all student populations.
4. Employ multiple, robust quality assurance protocols to provide defined benchmarks and measure training
effectiveness. The IAFF is dedicated to ensuring the training program meets and exceeds the NIEHS
Minimum Training Criteria Document resulting in workers who are safety-conscious, strong decision
makers, positive role models, and who may serve as worker-trainers in their field.